The effects of opioid use on HIV-1 reservoir dynamics

Abstract
HIV-1 persists in memory CD4+ T cells during suppressive antiretroviral therapy (ART) and is the major
barrier to virus cure. Ultimately, a successful HIV eradication approach will need to work equally well regardless
of disease stage, underlying immune system function, or medical comorbidities.
People with HIV are commonly exposed to opioids, whether prescribed for chronic pain,
prescribed for opioid use disorder, or injected as heroin. Opioid exposure has demonstrated immune modulatory
effects but the impact of opioids on HIV-1 reservoir dynamics has not been studied and thus there is an urgent
need for focused, mechanistic studies to address this critical knowledge gap. The purpose of this proposal is to
apply cutting-edge experimental approaches to understand precisely how opioids and opioid use disorders
impact HIV-1 reservoir dynamics and latency reversal and transform our ability to study and test HIV-1
eradication approaches in this important patient population. The scientific premise of this proposal is that opioids
limit HIV-1 transcriptional and translational reactivation due to a previously unrecognized block in RNA and
protein synthesis.
While the HIV eradication field has focused on transcriptional biomarkers of latency reversal, our
preliminary ribosome profiling data reveals that translation, not transcription, is the rate-limiting step in HIV-1
reactivation. Ribosome profiling is a novel technique that uses deep sequencing to characterize the nuclease-
protected footprints of ribosomes on mRNA transcripts in vivo. Protein synthesis can be monitored genome-wide
and when combined with mRNA sequencing (mRNA-seq) provides a quantitative measure of translation
efficiency. We propose to leverage HIV and host genomic information and investigate the mechanisms that
control HIV-1 latency reversal in patients using opioids. We hypothesize that opioid use will limit HIV-1 latency
reversal and lower HIV-1 translation efficiencies, when compared to HIV-1 latency reversal in the absence of
opioid exposure. To define the effects of opioids on traditional HIV-1 persistence markers in vivo, we will perform
a cross-sectional analysis among HIV-infected treated suppressed participants and quantify and compare
traditional HIV-1 persistence markers from 5 groups: individuals who are 1) actively injecting opioids (n=20), 2)
on methadone maintenance (n=20), 3) on buprenorphine maintenance (n=20), 4) on prescribed opioids for
chronic pain treatment (n=20), and 5) on no opioids (n=40). We will perform ex vivo reactivation experiments
with participants' PBMC and a panel of LRA. LRA-induced levels of HIV-1 caRNA and supernatant virion
production will be compared across opioid use groups. To accurately measure genome-wide host and HIV-1
translation in PBMC isolated from patients who use opioids, parallel mRNA-seq and ribosome profiling will be
performed. Finally, we will assess longitudinal HIV-1 reservoir dynamics in a group of 40 participants during the
transition from active injection opioid use to buprenorphine for opioid use disorder.

Public health relevance
Narrative HIV infection establishes a cellular reservoir that persists even after active and effective antiretroviral therapy is introduced. Although current eradication strategies aim to reactivate latent HIV transcription in the presence of suppressive antiretroviral therapy (ART) and then clear the reservoir, very little is known about the impact that opioid use, or treatment for opioid use disorder, will have on HIV-1 latency and our ability to reactivate virus transcription and induce the HIV-1 protein synthesis that will be required for immune-based cure strategies. Our study investigates the effects of opioids on HIV-1 reservoir dynamics, explores the impact of opioid use on LRA- induced HIV-1 translation efficiency across the host and virus genomes, will improve our understanding of HIV- 1 reactivation dynamics during a transition from opioid substance use to medication therapy, and will inform the design of next-generation strategies to eradicate the reservoir in people living with HIV who use opioids.